Genetically Linked Metabolites of Sepsis Severity and Mortality

Sepsis and its consequences such as organ dysfunction and failure remain significant human health problems.
We have identified blood metabolites (small molecular weight compounds) including a by-product of
mitochondrial fatty acid β-oxidation, acetylcarnitine (C2), that are associated with sepsis-induced organ
dysfunction and mortality. Additional preliminary data suggest that blood levels of C2 during sepsis is
associated with single nucleotide polymorphisms (SNPs) in the OCTN2 gene (SLC22A5; rs2631367,-
207C>G), the transporter that shuttles C2 out of cells. A SNP that is inconsequential in health, this gene and
several master metabolic regulator genes may have biological relevance in disease. Furthering understanding
of the associations between genetic variants and sepsis metabolite levels will bring insights to the mechanisms
that enhance or attenuate sepsis severity (organ dysfunction) and mortality as well as aid in identifying drug
target opportunities. Using the BioLINCC R21 mechanism we propose to conduct a preliminary metabolomics-
genome-wide association study (GWAS) by leveraging DNA and plasma biospecimens from The Crystalloid
Liberal Or Vasopressor Early Resuscitation in Sepsis (CLOVERS) trial. We will use the requested BioLINCC
stored plasma and paired DNA specimens from 600 CLOVERS participants to generate metabolomics and
GWAS data, respectively. We will test the central hypothesis that master metabolic regulator gene SNPs are
associated with metabolite blood levels that contribute to sepsis-induced organ dysfunction and mortality via
the following aims: Aim 1: Identify the genomic and patient level-factors that contribute to acetylcarnitine
blood levels in patients with sepsis. We will test associations between 114 SNPs of metabolic regulation,
fatty acid β-oxidation, and acylcarnitine transport and acetylcarnitine blood levels. Our working hypothesis is
that SNPs in genes involved in the regulation of fatty acid β-oxidation and the transport of acylcarnitines
contribute to the broad dynamic range of acetylcarnitine blood levels in patients with sepsis. Aim 2: Determine
genetic associations of differentiating metabolites of sepsis-induced organ dysfunction. We will use our
entire metabolomics data set which covers a broad range of different classes of metabolites, many of which
are expected to be associated with organ function. Using the wealth of genomic data from the GWAS, we will
test associations between each SNP and each differentiating metabolite. Our working hypothesis is that there
are genetic variant-metabolite associations that contribute to sepsis severity. We expect to identify 1) SNPs
associated with sepsis-induced increases in acetylcarnitine levels and 2) additional genetic variant-metabolite
associations linked to sepsis outcomes. Collectively, this work will advance understanding of molecular
mechanisms that underlie sepsis-induced amplification or attenuation of metabolic processes that contribute to
sepsis. The findings will also generate testable hypotheses for planned future R01 applications that will use the
entire CLOVERS cohort to generate whole genome sequencing and temporal metabolomics data.

Public health relevance
Sepsis remains a significant health problem for which the underpinnings are not well understood. We propose using existing biospecimens from a recently complete clinical trial (CLOVERS) to better understand the influence of genetics on the broad range in levels of small molecules (metabolites) we have observed in the blood of patients with sepsis. Identification of genetic-metabolite associations will aid in finding new therapeutic targets and processes that may put patients at higher risk for severe sepsis.